DEVELOPMENT OF APOLLO COMPUTER SYSTEM FOR MODELING MACROMOLECULES

A large part of the past year was spent learning the UNIX operating system, the C language, and the Silicon Graphics IRIS workstation. I have now developed a molecular graphic system on the IRIS in C. The system is particularly suited for a realtime manipulation of macromolecules. It is menu-driven so that even an occasional novice user can start using the system without prior preparation. By September 1986, we hope to link this graphics package with the energy minimization--molecular dynamics program that Dr. B. Brooks is developing on the STAR100. Once this linkage is completed, we will have one of the world's most powerful tools for modeling biological macromolecules.